Spatio-temporal cellular dynamics regulating differential healing outcomes

Project Summary / Abstract:
Healthy individuals have a tremendous intrinsic ability to heal after injury. Wound repair involves complex and
coordinated actions of various cell types acting across three sequential healing phases: Inflammatory,
Proliferative and Resolution. Efficient wound repair requires a timely progression from one phase of healing to
the next, with the ultimate goal of returning the injured tissue to homeostasis. Wounds of the oral cavity heal
faster than skin wounds, and their phases of healing are optimized to result in a more regenerative outcome. In
contrast, the phases of healing become corrupted by chronic diseases, leading to, on one extreme,
pathological tissue under-healing (as in diabetic and chronic wounds) and on the other extreme, pathological
tissue over-healing (as in carcinogenesis). However, studies that directly compare models of reparative skin
healing with optimized oral healing, or with disease models of pathological under- or over-healing, are lacking.
The overall goal of this MIRA research proposal is to understand the progression of healing phases across
differential healing outcomes at the spatio-temporal single cell level. We aim to discover critical junctions along
the healing continuum where healing becomes optimized (as in oral wounds) or pathological (as in chronic
wounds and tumors). Our approaches are innovative because we will use state-of-the-art single cell and spatial
sequencing technologies combined within a new spatio-temporal analytical framework to systematically
compare cell type dynamics, cell-cell interactions and cell-specific gene regulatory networks across mouse
models of successful and pathological healing.
In the first project, we will generate a new spatial single cell dataset of oral wound healing and use our
network-based analytical framework to identify cell-specific spatio-temporal gene signatures that distinguish
optimized oral healing from reparative skin healing. In the second project, we will apply this analytical
framework to identify healing-associated bottlenecks in datasets of pathological under-healing (diabetic skin
injury model) and over-healing (oral and skin carcinogenesis models). We will validate our findings using
existing datasets of human pathology, including those from diabetic chronic wounds and skin/oral cancers, and
then experimentally using orthogonal methods in cell and animal models of wound healing and carcinogenesis.
Overall, this proposal will increase our understanding of the complex cell population dynamics that result in
reparative, optimized or pathological healing outcomes. The projects will result in novel phase-resolved and
cell-specific gene expression signatures that describe healing-related stages of disease progression in
under-healing diabetic wounds and over-healing tumors. These signatures will have diagnostic, prognostic and
therapeutic value for targeting of specific cells and pathways, with the ultimate goal of promoting the healing of
surgical, traumatic and chronic wounds as well as inhibiting cancer progression.

Public health relevance
Project Narrative Healthy individuals have a tremendous ability to heal after injury, which involves complex and coordinated actions of various cell types acting across sequential healing phases in space and time. This project aims to understand how oral wounds, which heal better and faster than skin wounds, optimize the healing process, and how chronic diseases such as diabetes and cancer corrupt the healing process. We will focus on studying these differential healing outcomes using an innovative analytical approach that takes into account cellular dynamics across the healing continuum in both space and time, with the goal of identifying important gene signatures in cells that may lead to new targeted therapies for chronic wounds and tumors.